Cell Plasticity-Based Reprogramming Strategies to Enhance Human Myocardial Regeneration

Congestive heart failure (CHF) typically occurring as a result of myocardial infarction (MI) remains the leading
cause of cardiac mortality in the West. Recent CHF treatment research strategies focused on exogenous stem
cell administration have been largely disappointing - likely due to poor implant survival and integration into the
host myocardium. Cellular reprogramming, allowing the in situ transdifferentiation of cardiac fibroblasts into
induced cardiomyocyte-like cells (iCMs), represents a novel myocardial regenerative strategy that may abrogate
many challenges of stem cell delivery. However, recent findings that reprogramming factors which consistently
induce rodent cell transdifferentiation fail to reprogram human cells suggest that human cells are resistant to
reprogramming compared to rodent cells - an important new challenge to this field. We have developed two
prototypical “pro-plasticity” cell reprogramming strategies to test our central hypothesis that these strategies can
be used to critically facilitate human cell reprogramming as a means to improve post-MI cardiac function. These
pro-plasticity strategies are: 1) transcriptional activation of reprogramming pathways (via p63 downregulation
and Hippo pathway override), and 2) induction of a “trans-cellular” state using an endothelial cell differentiation
factor (ETV2 or VEGF) to transdifferentiate fibroblasts into an endothelial cell intermediary. Our corollary
hypothesis is that the efficacy of these pro-plasticity strategies can be ascribed to their de-repression of key
reprogramming gene activation by epigenetic mediators in higher-order species. The novelty of this work is
reflected in the three US patent applications we have filed regarding these discoveries. Our specific aims are
accordingly designed to test the hypothesis that each of these two pro-plasticity strategies can enhance human
cardio-differentiation and to test a third hypothesis that these strategies can be used to enhance cellular
reprogramming and thereby improve post-infarct cardiac function in vivo. In pursuit of these aims, we will use
single-cell RNA-seq and ATAC-Seq to identify cardio-differentiating genes and epigenetic factors that are
differentially repressed in human vs rodent cells and induced by pro-plasticity strategies and thereby “reverse
engineer” an optimized precision reprogramming cocktail derived from these factors. We will also use CRISPR
vs vector-based transgene overexpression strategies to optimize deliver of these reprogramming factors. We
will test these strategies in a rat coronary ligation and then a pre-clinical, porcine MI model, testing (AAV-
mediated) systemic vs direct myocardial administration strategies. Accomplishment of these aims could redirect
efforts in the novel field of cardiac cellular reprogramming and help elucidate a new clinical strategy for treating
CHF.
1

Public health relevance
Congestive heart failure (CHF) remains the leading cause of cardiac mortality in the West. Cellular reprogramming represents a promising new myocardial regenerative strategy for treating CHF, and our proposal seeks to overcome barriers to human cardiac cell reprogramming as a potent new CHF therapy.